Project 2: Targeting CXCR4 and Redox Metabolism for Targeted Alpha Therapy of Pulmonary Neuroendocrine Tumors and Carcinomas

Project 2 – Summary / Abstract
Atypical carcinoids of the lung and neuroendocrine carcinomas (NECs) are currently incurable with most
patients succumbing to disease within five years. A subset of pulmonary neuroendocrine tumors (NETs) and
NECs (including small cell lung cancer [SCLC]) initially respond to chemotherapy or to radioligand therapy
(RLT) targeting somatostatin receptor type 2 (SSTR2). However, resistance to therapy invariably develops and
many of these tumors lack or lose SSTR2 expression such that metastases, progression, and mortality occurs
in most cases. This creates a critical need for new therapeutic strategies. Our exciting preliminary data show
these lung tumors highly express the G protein coupled receptor, C-X-C chemokine receptor 4 (CXCR4) and
can be effectively targeted therapeutically using 212Pb-pentixather (212Pb-pent) in preclinical models.
Furthermore, 203Pb-pent can be used in preclinical models to calculate radiation doses to tumor and normal
target organs (kidney, liver, bone marrow) to limit normal tissue toxicity making this theragnostic pair
(203Pb/212Pb) attractive for clinical development. Importantly, the high linear energy transfer (LET) unique to
alpha particles from 212Pb-pent generate dense ionization tracts in the cytoplasm that damage metabolic
structures such as mitochondria, leading to metabolic generation of hydroperoxides. The presence of
hydroperoxides can selectively enhance tumor cell kill when combined with inhibition of hydroperoxide
metabolism using an FDA approved, thioredoxin reductase inhibitor (Auranofin; Aur) while causing minimal
normal tissue injury. The overall hypothesis is targeting CXCR4 with 212Pb-pent in atypical carcinoids and
lung NECs combined with inhibition of hydroperoxide detoxification will enhance the responses to
212Pb-pent alpha particle radiation therapy. Our hypothesis is tested in 2 Aims.
Aim 1: Determine if inhibiting hydroperoxide metabolism with Aur induces selective enhancement of 212Pb-
pent alpha particle therapeutic efficacy in preclinical models of lung NETs and NECs by hydroperoxide
mediated oxidative stress.
Aim 2: Conduct a Phase 1 trial of alpha emitter dosimetry guided PRRT with 212Pb-pent in patients with
atypical lung NETs and pulmonary NECs including SCLC.
SIGNIFICANCE: Successful completion of Aim 1 will result in a high impact biochemical-based paradigm shift
in the treatment of lung NETs and NECs. CXCR4 will be targeted with high LET 212Pb-pent and the anti-tumor
effects enhanced by exploiting cancer cell-specific hydroperoxide-mediated metabolic oxidative stress. Aim 2
will optimize safety, clinical imaging, and dosimetry for evaluation of CXCR4 receptors for targeting of atypical
carcinoids and NECs with 212Pb-pent in anticipation of future Phase 2 clinical trials. Overall, Project 2 will
provide mechanistic and clinical information that will have a lasting impact on the development of 212Pb-pent for
improving outcomes in currently incurable neuroendocrine lung cancers.

Public health relevance
Project 2 – Narrative Atypical carcinoids of the lung and lung neuroendocrine carcinomas (NECs) are currently incurable with most patients succumbing to disease within five years after diagnosis. This Project will pursue the development of an exciting new treatment paradigm for these cancers based on high LET alpha radioligand therapy (RLT) with 212Pb Pentixather targeting the CXCR4 receptor combined with cancer cell specific manipulations of metabolic oxidative stress. The studies will optimize clinical imaging, therapy delivery, and dosimetry techniques and, if successful, will have lasting impact on improving outcomes for neuroendocrine lung cancer patients.